Blood Pressure and ADRD in African Americans: the Jackson Heart Study

PROJECT SUMMARY/ABSTRACT
Rates of mild cognitive impairment (MCI) and dementia are two to three times higher among African Americans
(AAs) than among White older adults. Observational and clinical trial data, most recently from the Systolic
Blood Pressure Intervention Trial: Memory and Cognition in Decreased Hypertension (SPRINT-MIND), support
that blood pressure is the most important modifiable vascular risk factor for MCI and dementia. However, the
short duration of follow-up in SPRINT-MIND coupled with the failure to detect a statistically significant benefit of
a lower blood pressure goal for incident dementia means that longer-term observational data will be necessary
to fully address the implications of the clinical trial results. These questions are particularly salient for AAs, who
have earlier onset of high blood pressure and are at higher risk of dementia, in particular cerebrovascular
pathology. Even after considering race/ethnic differences in blood pressure level, the mechanisms underlying
racial disparities in risk for dementia are not well understood. Additionally, despite facing a high burden of high
blood pressure, some individuals are resilient, achieving better-than-expected outcomes. The specific factors
that contribute to brain-health resilience are not well established. We propose to address these research gaps
in an ancillary study to the 2020-2022 4th examination of ~2,700 participants in the Jackson Heart Study (JHS),
an ongoing cohort study of well-characterized AAs. The JHS Exam 4 will include brain magnetic resonance
imaging (MRI) data to ascertain cerebrovascular disease and neurodegeneration. We propose to add
measures of cognition and function sufficient for classification of MCI and dementia, and innovative plasma
biomarkers of amyloid (Ab42, Ab40), tau, and neurodegeneration (neurofilament light). The primary aims are
as follows: Aim 1. Estimate the long-term associations of exposure to high 20-year time-weighted average
blood pressure and blood pressure load on (1) cognitive performance; (2) prevalence of MCI and dementia; (3)
markers of cerebrovascular disease and neurodegeneration quantified from MRI; and (4) plasma amyloid, tau
and neurodegeneration. Aim 2. Examine whether sex, educational quality (i.e. reading level measured with the
WRAT), and APOE-e4 and ABCA7 genotype, modify the associations of long-term exposure to high blood
pressure and blood pressure load with cognitive outcomes. This study is responsive to PAR-19-070 and NOT-
AG-18-047 (Health Disparities and Alzheimer’s Disease) by adding cognitive assessments to a landmark
cohort study of cardiovascular disease in AAs; leveraging existing and new data to understand risk and
resilience factors for cognitive impairment; and drawing on the JHS cohort to understand vascular mechanisms
underlying cognitive impairment in a minority population. This study is also proposed in the context of the
updated National Institute on Aging/Alzheimer’s Association research framework in which the constructs of
amyloid, tau, and neurodegeneration are featured prominently. Lastly, results from this study will inform future
research and have implications for policies intended to improve brain aging in minority populations.

Public health relevance
PROJECT NARRATIVE This study will quantify the prevalence of mild cognitive impairment (MCI) and dementia, examine the associations of long-term exposure to high blood pressure with established and novel measures of brain health, and determine the role of biologic factors and social determinants of health in modifying the risk of MCI and dementia among African Americans. The aims of the current proposal will both leverage extant data from the Jackson Heart Study (JHS), and add to the study measures of cognitive function sufficient for classification of MCI and dementia phenotypes and novel plasma biomarkers of Alzheimer’s disease neuropathology at the JHS reexamination of cohort members in 2020-2022. This study is responsive to the recommendations from the National Alzheimer’s Project Act, and will both inform future research on vascular determinants of cognitive function and have significant implications for policies intended to improve brain aging, risk for dementia, and minority health.